ISEH 53rd Annual Scientific Meeting

The International Society for Experimental Hematology’s (ISEH) 53rd Annual Scientific Meeting
will be held 29 August – 01 September 2024 at the Sheraton Grand Chicago in Chicago, IL.
Through this R13 application, ISEH seeks support for young investigator attendance and
participation in its 2024 scientific meeting.
Our scientific program highlights talks on basic, translational and clinical hematology. The
meeting is structured to include one day of pre-meeting workshops for PhD students,
postdoctoral fellows and junior faculty, followed by three days of world-leading scientific talks
and networking activities for all attendees. Scientific talks include a combination of invited
speakers and oral abstract presentations featuring the latest scientific achievements and
unpublished research. The ISEH Scientific Programming Committee intentionally includes
world-renowned scientists, while also providing opportunities for the field’s rising stars to present
for the first time at an international scientific meeting, developing future scientists.
In addition to the science, the size and setting of the ISEH meeting creates unmatchable
networking opportunities connecting young investigators with prestigious senior faculty to
meaningfully discuss research, techniques, technology, publications, and career opportunities in
a safe, inclusive and welcoming environment. Early career investigators (PhD students,
postdoctoral fellows and junior faculty) accounted for 61% of our attendees in 2023.
Our New Investigators and Junior PI Committees guide the development of these activities
targeted to junior (new) investigators, which is a critical differentiator of the ISEH meeting. In
2024, ISEH will host activities including a pre-meeting workshop, career development sessions
for PhD and Postdocs, a Junior Faculty forum discussion, a new technology session, a
meet-the-experts mixer, a Junior Faculty mixer, as well as featured poster presentations and
oral presentations. Additional support for young investigators participation includes a travel
grant program, in which young investigators can apply for funding to support meeting costs
when submitting an abstract to defray costs of attendance at the meeting.
It is our goal that these activities fulfill ISEH’s mission to promote the scientific knowledge and
clinical application of basic hematology, immunology, stem cell research, cell and gene therapy,
and all related aspects through research, publications, discussion, support of young
investigators and organization of scientific meetings.

Public health relevance
The International Society for Experimental Hematology’s (ISEH) Annual Scientific Meeting blends high-impact scientific sessions with approachable networking opportunities to create an important forum for scientists at every level of their career, including students, postdoctoral fellows, junior faculty, and senior faculty who focus on advancing the areas of hematology, hematologic disorders, stem cell biology, cell therapy and immuno-oncology. Our scientific program is structured to include one day of pre-meeting workshops for PhD students, postdoctoral fellows and junior faculty, followed by three days of world-leading scientific talks and networking activities for all attendees. Through a mixture of invited speakers and oral abstract presentations featuring talks on basic, translational and clinical hematology, ISEH is known as a meeting to both hear the latest scientific achievements and unpublished research, as well as an opportunity for field’s rising stars to receive their first opportunities to present at an international scientific meeting in an inclusive, safe and welcoming environment. The critical networking enabled at ISEH’s meeting advances the next generation of scientific leaders in experimental hematology, resulting in the translation of discoveries into drug development and critical therapies.